Genomic and Immunologic Characterization of Inflammatory Bowel Disease and its Phenotypes

Project Summary/Abstract
To date more than 200 genetic variants are known to be associated with inflammatory bowel disease (IBD).
The majority of these have been identified by genome-wide association studies (GWAS). The individual
Genetic Research Centers (GRCs) and the collective NIDDK IBD Genetics Consortium have successfully
interacted for the last fifteen years to lead many of these discoveries. However, despite significant progress it
is still unknown how the majority of these variants or other risk factors lead to development of IBD and its two
major subtypes - Crohn’s disease (CD) and ulcerative colitis (UC). Answering these questions is critical to
advancing our knowledge of IBD pathophysiology.
Since 2002, Dr. Silverberg has established a very large, comprehensive registry of well characterized,
longitudinally followed IBD patients at Mount Sinai Hospital in addition to accompanying biospecimens stored
at his laboratory at the Lunenfeld-Tanenbaum Research Institute to facilitate research in IBD. Utilizing these
resources and applying new expertise in cellular, genomic and immune profiling, it is anticipated that the
proposed studies will help to make significant progress in the unmet needs described above. The IBDGC
working together with the UTGRC will study comprehensively the genetic architecture of non-European
ancestry IBD populations and utilize the power of its infrastructure to better elucidate the pathophysiology of
acute severe ulcerative colitis and perianal Crohn’s disease. The UTGRC, specifically, will advance the
understanding of UC pathophysiology by integrating imaging mass cytometry, spatial transcriptomics and
scRNA-seq, in conjunction with tissue-associated microbiome analysis, to develop a comprehensive
understanding of the immune, genomic, cellular and microbial factors that contribute to persistent histologic
inflammation and mechanisms of clinical relapse in UC. Utilizing the power of these technologies, also
provides a unique opportunity to go “back in time” to study critical events that lead to the development of
colorectal cancer in UC – a poorly understood complication with significant mortality. By applying similar
techniques in a retrospective cohort, the cellular and immune factors that lead to treatment refractory CD.
Despite the progress in advanced biologic therapy, there are still a significant portion of patients who fail
multiple therapies and have persistent inflammation. Taken together, through the studies proposed, it is
anticipated that significant advances will be made toward better understanding the functional biology of IBD
genetic variation and to enable the translation of these data to clinically meaningful tools that will lead improved
outcomes for individuals affected by IBD.

Public health relevance
Project Narrative The University of Toronto Genetic Research Center, working within the NIDDK IBD Genetics Consortium, is proposing a series of studies aimed at transforming the knowledge gained through genetic studies in IBD into functional biology that can impact patient care in the near term. While ultimately the goal remains to prevent IBD from occurring, these studies aim to reduce the risk of relapse in ulcerative colitis, through better understanding of the biology of persistent inflammation in contributing to relapse and colorectal cancer risk and to elucidate the immune and cellular profile of treatment refractory Crohn’s disease. Through the insights gained, we hope to improve the quality of life of individuals affected by IBD in the near future while continuing our long-term goals to prevent IBD from arising in the first place.